Biopsychosocial predictors of obesity during the first 2 years of life

Project Summary
The prevalence of childhood obesity is a significant public health crisis. Overweight children experience
significantly more health and psychosocial problems compared to their same age peers and are likely to carry
these problems with them into adolescence and adulthood. In this proposal, we describe a study of the early
development of risk for obesity in childhood. The risk for obesity in early childhood is likely determined by
multiple biological, psychological, and social factors that are observable in infancy. We proposed a conceptual
model, a biopsychosocial model, of the early development of risk for obesity that focuses on several key
biological, psychological, and social factors. Using an experienced team of investigators from multiple
disciplines, we proposed to investigate this model with an innovative, multi-method, longitudinal study of infants
and their families (n = 300) beginning in the prenatal period that addresses these factors across the first two
years of life. Our two key aims focus on understanding (1) factors that predict infant weight gain in the first 6
months of life and (2) the ways in which this weight gain and infant’s social interactions with mothers in feeding
and non-feeding contexts predict self-regulation, and subsequent obesity risk at age 2. The study has
important implications for the development of targeted prevention and intervention programs for families and
children that may be utilized early in development, prior to the onset of weight gain that is difficult to reverse.
The purpose of this supplement is to seek funds, primarily for personnel, to complete the original study aims
despite COVID-related delays in recruitment and data collection.

Public health relevance
Project Narrative This project has clear public health implications, as it focuses on childhood obesity, a problem that has implications for both health and psychosocial functioning. Understanding the different pathways to weight gain in infancy and risk for obesity in early childhood will lead to an appreciation of the multiple points of entry for prevention and targeted interventions.